Research Training in Academic Cardiology

Abstract
This application requests continued support for the highly successful postdoctoral training program in
cardiovascular research in the Division of Cardiology at Emory University School of Medicine. The proposed
program will extend our laboratory, translational and clinical research curriculum that has developed an
impressive record of training outstanding postdoctoral fellows. The Emory University Cardiology Research
Division has become recognized as a leader in cardiovascular research. The mentors included in this application
provide a broad-based, multidisciplinary environment ideally suited to provide an outstanding educational
experience for trainees. Participating faculty are drawn from multiple Divisions/Departments at Emory University
and Georgia Tech. All have established funding and publication records as well as documented success in
training productive members of the scientific community. The training program is structured around a mentor-
based environment supplemented with an extensive array of didactic educational opportunities. In summary, the
proposed cardiovascular research training program will provide a unique opportunity for multidisciplinary training
in basic and clinical cardiovascular biology. We are requesting a total of 10 fellowship slots each year, with the
expected duration of two year terms for each trainee. Trainees will be well-equipped to initiate careers in
cardiovascular research through the anticipated outcomes of submitting research grant applications as well as
preparing, submitting and presenting abstracts for local and national research meetings. Successful trainees will
also be expected to contribute to collaborative research articles submitted for publication as well as generating
first author publications to be submitted to leading peer reviewed journals.

Public health relevance
Narrative We propose a continuation of a postdoctoral training program in cardiovascular research at Emory University School of Medicine. Trainees in this multidisciplinary environment will be well equipped for research careers in academic cardiology.